Training Grant in Genetics

The proposed Training Grant in Genetics is the centerpiece in efforts to provide postdoctoral research training
in medical genetics in the Harvard Medical School (HMS) Genetics Training Program (HMSGTP) with an
overall goal to train the future academic leaders of this discipline. The requested number of trainees per year
is eight, and these individuals will join the training program largely with experience in a variety of medical
specialties, having completed residency training in a relevant discipline or enrolled in combined residency
programs with medical genetics. Recent advances in genetics and genomics, in particular the sequencing of
the human genome, have dramatically accelerated the pace of research in this area. Genetics and genomics
are currently the major drivers of medical research, and promise to lead to advances in diagnosis and
treatment of both rare and common disorders. Implementation of the many advances in genetics requires a
well educated and talented workforce of genetics professionals. The Training Grant in Genetics has made
possible the opportunity to offer training to physicians and scientists in a wide variety of topics in medical
genetics, enabling them to take advantage of the extraordinarily rich academic environment present at HMS
and its affiliated institutions as well as the greater Boston scientific community. In addition, it has served to
promote interactions between medical geneticists and investigators and provided a forum for increasing faculty
contact with trainees in didactic sessions. Training laboratories of the HMSGTP have historically been
centered now for four decades at HMS and its affiliated institutions including Brigham and Women's Hospital
(BWH), the HMS Department of Genetics, Beth Israel Deaconess Medical Center (BIDMC), Boston Children's
Hospital (BCH), Dana Farber Cancer Institute (DFCI), and Massachusetts General Hospital (MGH), and also
include laboratories at the Massachusetts Institute of Technology (MIT) and the Broad Institute. Since the last
renewal of this training grant, a large variety of opportunities in genomic medicine have developed to enhance
the focus of training in medical and human genetics, and the program is fully integrated with the HMS
American Board of Medical Genetics and Genomics (ABMGG) training program, accredited by the ABMGG in
all areas of training (Clinical Biochemical Genetics, Clinical Cytogenetics, and Clinical Molecular Genetics) and
by the ACGME in all relevant areas (Clinical Genetics and the two subspecialties of Medical Biochemical
Genetics and Molecular Genetic Pathology) and in all areas of combined training with medical genetics leading
to dual board certification (Internal Medicine/Medical Genetics, Pediatrics/Medical Genetics, Maternal-Fetal
Medicine/Medical Genetics, Neonatology/Medical Genetics), providing the opportunity for trainees to become
active candidates for the certification examination in a discipline(s) of medical genetics in addition to receiving
research training for two to three years.

Public health relevance
The proposed program provides postdoctoral research training in medical genetics with an overall goal to train future academic leaders who will apply this knowledge to an understanding of human genetic disorders. Through rigorous training in the principles of genetics, trainees will exploit recent advances in genetics and genomics to discover the pathogenesis and pathobiology of inherited disease, and to use this information to improve human health. Understanding the etiology of heritable disease will lead to molecular classification, inform risk of recurrence, facilitate development of novel and more effective therapies to reduce illness and disability, and has potential to reduce costs in healthcare through stratification of patients for treatment and management based on the underlying genetic basis of their conditions.